X-ray micro tomography of pathology tissue samples

This is a collaboration with Dr. Alan Remaley of NHLBI, Dr. Alexander Bocharov of the Clinincal Center Department of Laboratory Medicine, and Dr. Teru Yoshida of Dr. Jeff Kopp's lab in NIDDK. Using an x-ray microscopy technology we developed previously, we perform non-invasive measurements of the amount of tissue calcification in intact, fresh moue aorta samples for the various genetically modified moue models from our collaborators. Given that each batch of samples contain a dozen or more individual samples that need to be analyzed, this year we upgraded a semi-automatic software that assists the operator in labeling the calcification in a batch of samples. We provided measurements to batches of mouse aorta samples of Dr. Bocharov of the Clinical Center. Additionally our work with Dr. Yoshida from Jeff Kopp's lab in NIDDK contributed to the publication "Yoshida, T.; Yang, Z.-H.; Ashida, S.; Yu, Z. X.; Shrivastav, S.; Rojulpote, K. V.; Bahar, P.; Nguyen, D.; Springer, D. A.; Munasinghe, J.; Starost, M. F.; Hoffmann, V. J.; Rosenberg, A. Z.; Bielekova, B.; Wen, H.; Remaley, A. T.; Kopp, J. B. Apolipoprotein-L1 G1 Variant Contributes to Hydrocephalus but Not to Atherosclerosis in Apolipoprotein-E Knock-out Mice. Clinical Science 2025, 139 (11), 559–575. https://doi.org/10.1042/CS20255324."